A Community-based Assessment of Skin Care, Allergies, and Eczema: The CASCADE Trial

PROJECT SUMMARY
Atopic dermatitis (AD) affects over 9 million children in the U.S. and ranks first among all skin conditions in
global disability burden. Atopic dermatitis often heralds the development of several comorbid conditions
including asthma, food allergy, skin infections and neurodevelopmental disorders. Because of the significant
socioeconomic impact of atopic dermatitis and its effect on the quality of life of children and families, there
have been decades of research focused on prevention with limited success. Recent advances in cutaneous
biology identify epidermal defects and skin barrier dysfunction to be the key initiators of AD and possibly
allergic sensitization. Our central hypothesis is that daily emollient use from birth can prevent the development
of AD.
Recently, our international multi-centered clinical trial found enhancing early skin barrier function with daily
emollient use from birth significantly reduces the risk of AD development in high-risk populations by 50%. In
this current proposal, to better guide skin care recommendations for all newborns, we extend our approach into
a community setting and into newborns unselected for risk. The results of a community-based clinical trial
utilizing a pragmatic trial design will be immediately applicable to the population at large and will establish a
new standard of care for all newborns. A prevention strategy that reduces AD prevalence by just 20% would
save hundreds of millions of dollars annually in U.S. healthcare expenditures and reduce the overall disease
burden for millions of children. Under a NIAMS U34 planning grant, our multidisciplinary team spent the last
two years creating a clinical trial management infrastructure, developed and refined a study protocol and
accompanying regulatory documents, and recruited 25 primary care practices from Oregon, Colorado,
Wisconsin, and North Carolina. We are now poised to successfully complete the following aims of the current
study: 1) Perform a pragmatic community-based randomized controlled trial investigating whether daily full-
body emollient therapy starting in the first 2 months of life prevents atopic dermatitis in a real-world setting and
2) As an exploratory analysis, determine whether a family history of allergic disease and key early life
exposures such as pet ownership modify the preventive effect of emollient therapy on AD. Given the
experience and expertise of our multi-disciplinary team, we expect to successfully complete both aims of this
proposal in the 5-year award period. The expected results from this U01 project represent a major public health
breakthrough with the potential for reducing the AD burden on a global scale.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to the NIH mission because its primary objective is to prevent atopic dermatitis, a disease with a worldwide distribution and high prevalence. In addition, the strategy is a simple, low-cost and safe intervention that may also reduce the risk of children developing other diseases like food allergy. The strategy under investigation is one that could be readily implemented into current medical practice and could create an immediate positive public health impact.